The impact of aging on neutrophil-mediated protection and inflammation in the female genital mucosa

PROJECT SUMMARY
Urogenital infections, including sexually transmitted infections and other genitourinary tract infections, are a
major source of morbidity and mortality in older women, yet how aging impacts mucosal immune protection in
the female genital tract (FGT) remains largely unknown. Thus, to enable the development of preventive
approaches effective in younger and older women, it is critical to identify the early mucosal mechanisms that
confer protection from infection in the FGT and learn how aging alters these protective mechanisms.
Neutrophils are key cells for first-line innate protection and are involved in responses to genital infections,
including bacterial, fungal, and viral pathogens. Neutrophils are also involved in physiological reproductive
functions and are the first-responder cells to sites of injury to initiate the wound healing process. While the
presence of other immune cell types declines with age in the FGT, neutrophils remain constant. However, despite
neutrophils’ critical role in innate protection and tissue homeostasis, and their continual presence in the FGT with
age, the extent to which aging impacts FGT neutrophil-mediated protection against infection or tissue
inflammation as women age is unknown.
The PI’s research group recently discovered that, despite neutrophil presence in the FGT of older women, their
antiviral responses are compromised. Using novel multi-omics technologies, they have identified different
subsets of neutrophils with defense and homeostatic functions, and defined neutrophil intra-tissue spatial
location and transcriptional profiles in younger women. Building on these preliminary results, the central
hypothesis is that aging modifies tissue distribution and function of specific neutrophil subsets, leading to
decreased neutrophil-mediated mucosal protection and increased tissue inflammation in the FGT as women
age.
Using human hysterectomy samples from endometrium, endocervix, and ectocervix from younger and older
women, this project will combine multi-omics single-cell sequencing approaches, tissue spatial transcriptomics,
and in vitro functional assays of genital neutrophils to define how aging modifies neutrophil defense and
homeostatic functions, tissue distribution, and their contribution to first-line mucosal protection.
It is expected that these studies will define, for the first time, the mechanisms responsible for neutrophil-mediated
protection in the FGT and how they are modified with aging. The identification of an inducible/modifiable form of
innate protection in the FGT and how aging modifies this protection will have a positive translational impact,
enabling the development of novel strategies for protection against sexually-transmitted infections and other
genitourinary tract infections in older women, a group that is generally excluded from STI prevention research.

Public health relevance
PROJECT NARRATIVE To prevent morbidity and mortality in older women and enable medical advances, the defense mechanisms that protect the female genital tract (FGT) from infection and are impaired with aging need to be identified. This proposed research will investigate defense mechanisms that exist in neutrophils. The identification of targetable mechanisms that improve protection against infections in the FGT will open new pathways for the development of prevention strategies for all women as they age.